Structure-based design of antifungal inhibitors targeting the glycosylphosphatidylinositol (GPI) ethanolamine phosphate transferase, Mcd4

The Center for Disease Control (CDC) and World Health Organization (WHO) have both recently emphasized a
critical need for the development of new antifungal agents with novel mechanism of action(s) (MOA) to address
expanding clinical resistance to standard of care (SOC) antifungal therapeutics, emerging fungal pathogens, and
the unacceptably high rates of morbidity and mortality associated with invasive mycoses despite current
treatment options. Candida albicans is the principal clinically relevant invasive fungal pathogen in the U.S. and
a leading cause of bloodstream infections (Candidemia). The recent emergence of C. auris is also alarming as
it is often multidrug resistant to most if not all antifungal drug classes. Aspergillus fumigatus is the principal mold
pathogen and is the cause of Invasive Aspergillosis, where mortality rates can exceed 50% despite SOC
treatment. Only three major drug classes exist to treat life-threatening infections: amphotericin B (and various
formulations), azoles, and echinocandins. Each drug class, however, possesses its own limitations (spectrum,
administration, resistance, drug-drug interactions, and/or toxicity). Also concerning, few mechanistically novel
antifungals have advanced beyond Phase 1 clinical development. One exception is Fosmanogepix (FMGX), a
potent and selective inhibitor of glycosylphosphatidylinositol (GPI) biosynthesis. GPI biosynthesis serves as an
attractive antifungal drug target as enzymes involved in this pathway are highly conserved and essential for
fungal growth. We have identified the natural product, M743, which also inhibits GPI biosynthesis but by inhibiting
a distinct (Mcd4-mediated) step in the pathway. M743 offers significant antifungal drug development advantages,
including 1) potent and broad spectrum in vitro antifungal activity against multiple WHO-designated Critical
Priority Fungal pathogens, 2) a novel MOA to overcome existing clinical drug resistance mechanisms, 3)
preliminary in vivo efficacy, 4) synergistic activity in combination with manogepix (the active form of FMGX), and
5) the future opportunity to benefit from FMGX clinical development learnings. To assist its development, we
propose to perform cryo-EM studies to identify key molecular contacts between M743 and its fungal target versus
the human ortholog, PIG-N. These studies will guide hypothesis-based med chem synthesis of new analogs to
explore the opportunity of rationally improving fungal potency and selectivity of the series. Specific Aims: Aim
1. Expression, purification, and high-resolution cryo-EM structural elucidation of C. albicans (Ca) Mcd4 as well
as its human ortholog, PIG-N in apo and M720-bound form. Milestone 1. Obtain high-resolution structures (<
2.80 Å) of CaMcd4 and PIG-N in both apo and M720-bound form. Aim 2. Hypothesis-driven med chem synthesis
of up to 30 new semi-synthetic analogs based on Aim 1 structural insights to identify new analogs displaying
improved antifungal selectivity while maintaining or improving existing potency of M743. Milestone 2. Identify
(n > 1) new analogs with reduced cytotoxicity against HepG2, HEK293, and Caco-2 cell lines (TI> 200) while
maintaining or improving Candida and Aspergillus whole-cell activity and CaMcd4 IC50 versus M743.

Public health relevance
Narrative Widespread azole resistance among Candida and Aspergillus spp. along with emerging echinocandin resistance in C. glabrata and C. auris raises the specter of untreatable multidrug resistant fungal infections, and advances in medicine (cancer chemotherapy, organ transplant, premature infants, HIV/AIDS therapy) have increased the size of the vulnerable population. In October 2022, the World Health Organization (WHO) published a report on the first global effort to prioritize fungal pathogens (WHO Fungal Priority Pathogens List), and Candida and Aspergillus species were placed in the most critical priority group, highlighting the need to develop mechanistically novel antifungal agents against these pathogens. This project aims to develop a novel therapeutic targeting a recently clinically validated and essential cell wall biosynthetic pathway (Glycosylphosphatidylinositol; GPI) to treat life-threatening fungal infections due to drug resistant Candida and Aspergillus with no cross resistance to existing agents.